Photodynamic therapy with prior inhibition of epidermal growth factor receptor to stimulate antitumor innate immune response

PROJECT SUMMARY/ABSTRACT
Inhibition
remarkably
clinical
with
most
priming
therapy,
of epidermal growth factor receptor (EGFR) prior to the delivery of photodynamic therapy (PDT) can
improve treatment efficacy in animal models of non-small cell lung cancer (NSCLC). Currently,
use of EGFR tyrosine kinase inhibitors (TKIs) for treatment of patients with NSCLC is limited to those
EGFR mutated disease. EGFR-TKI therapy is typically continued until time of disease progression since
patients eventually develop EGFR-TKI resistant disease. Here, we propose to use EGFR-TKIs as a brief,
therapy for several days rather than as a daily continuous therapeutic. Importantly, as a priming
we hypothesize thatEGFR-TKI pretreatment will improve the therapeutic efficacy of PDT (and ionizing
radiotherapy, XRT) through an innate immune response-dependent mechanism.
the
EGFR
EGFR-TKI
priming
involve
EGFR-TKIs
damage
Indeed,
demonstrate
TKI/PDT).
lymphocytes
cells)
innate
notwithstanding
investigate
clinical
XRT.
vascular
augments
and
demonstrate
Significantly, we posit that
use of EGFR-TKIs as a priming approach to stimulate innate immunity is relevant to patients with
wild-type disease. However, its potential efficacy may not be apparent in the setting of daily continuous
therapy due to suppression of innate and adaptive immunity by prolonged use of EGFR-TKIs. As a
therapy, EGFR-TKIs could augment responses to PDT and XRT through multiple mechanisms that
cooperation between the EGFR-TKIs and PDT or XRT to promote tumor-directed innate immunity.
may increase neutrophil activation in tumors receiving PDT or XRT, serving to increase vascular
and/or stimulate other cells of the innate immune system, such as innate immune lymphocytes.
our published data show EGFR-TKI to increase vascular damage to PDT, and preliminary data
increases in tumor-localized neutrophil activation when PDT is preceded by EGFR-TKI (EGFR-
Additionally, EGFR-TKIs and PDT or XRT may cooperatively increase numbers of innate immune
and the immunologic visibility of target cells (e.g., tumor cells or tumor-associated endothelial
to these lymphocytes. In fact, in preliminary data the efficacy of EGFR-TKI/PDT is dependent on the
immune lymphocytes NK and  T cells. We note that the role of  T cells in response to EGFR-TKI,
combinations with PDT or XRT, is a novel area of investigation. Moreover, we uniquely
EGFR-TKI priming with proton XRT. Knowledge gained from this proposal will guide selection of a
approach to EGFR-TKI priming with radiation therapy, whether it be with PDT, photon XRT, or proton
Toward this goal, we will address the following aims: To define the role of neutrophils in promoting
damage when PDT is preceded by EGFR-TKI. To ascertain how pretreatment with EGFR-TKI
the response of innate immune l ymphocytes to PDT-treated tumors. To establish the efficacy
innate immune effects of EGFR-TKIs combined with ionizing radiation therapies (photon and proton) and
application in control of lung metastasis.
Aim 1.
Aim 2.
Aim 3.

Public health relevance
PROJECT NARRATIVE Non-small cell lung cancer (NSCLC) makes up over 80% of new lung cancer cases in patients, the majority of whom present with advanced stage disease and for whom standard frontline treatment will include tyrosine kinase inhibitors (TKI) of epidermal growth factor receptor (EGFR) if their disease contains EGFR sensitizing mutations. EGFR-TKI eventually therapy therapy is typically continued until time of disease progression since most develop EGFR-TKI resistant disease, but here we propose to use EGFR-TKI as a brief, for several days prior to photodynamic therapy (PDT) or ionizing radiation (XRT) in order to patients priming augment innate immune response to PDT (and XRT) in a manner that is applicable to patients with either wild-type or mutant EGFR expressing cancers. Toward these goals, we propose that it is important for EGFR-TKI to be delivered as a priming therapy because prolonged use can abrogate immunity; thus both the biological mechanisms and intended clinical application of our proposed approach serve to distinguish it from prior research.